Leadership and Administrative Core

ABSTRACT: LEADERSHIP AND ADMINISTATIVE CORE
The Leadership and Administrative Core (LAC) of the Michigan Center for Contextual Factors in Alzheimer’s
Disease (MCCFAD) promotes the two long-term goals of the Center to: (1) Advance Alzheimer’s Disease and
Related Dementias (ADRD) relevant social and behavioral science research in underserved and
underrepresented communities; and 2) Diversify the research workforce dedicated to ADRD. We engage with
three underserved groups with unique histories in Michigan: Middle Eastern North African (MENA) Americans,
Latinos and African Americans. ADRD research and community based relations with MENA and Latinos are
developed specifically within this project; whereas, thanks to our UM colleagues, we capitalize on the already
developed research and community based relations with African Americans developed by the Michigan Center
for Urban African American Aging Research (MCUAAAR) and the Michigan Alzheimer’s Disease Research
Center (MADRC). The LAC ensures integration and coordination of all MCCFAD activities through effective
interactions, communication, and information flow. Further, it leverages existing resources at the University of
Michigan (UM) and partner institutions (Michigan State University, Wayne State University, Oakland University,
UM-Dearborn) to enable unique linkages for collaborative mentoring and research. Fundamental to the Center
are the pilot projects of the AD-RCMAR Research Scientists. Therefore, the LAC provides oversight and
support for the solicitation and selection of pilot projects for funding and for the recruitment of Research
Scientists for the Center’s Enrichment and Summer Data Immersion programs. This AD-RCMAR focuses on
social and behavioral research that examines contextual factors that influence the experience of ADRD among
different groups. To conduct high quality research in these areas, research should include community
members in all aspects of the research. In conjunction with the Community Liaison and Recruitment Core, the
LAC will continue to build and sustain community partnerships in the most culturally sensitive and appropriate
manner possible. And finally, the LAC ensures organizational and fiscal integrity, program effectiveness, and
compliance with all relevant rules, regulations, and ethical principles. We maximize the use of technology to
implement a structure of segmented responsibility and strong oversight that includes counsel from Internal and
External Advisory Boards as well as Community Partner Boards and Health Professional Steering Committees.
In sum, the LAC oversees, manages, directs, and supports all other MCCFAD Cores to assure that it enriches
the conduct and quality of research on contextual factors in ADRD and ADRD inequalities while also increasing
the diversity of the ADRD workforce.